Consequences of Elevated Fibroblast Growth Factor 23 in the Presence and Absence of Kidney Disease

PROJECT SUMMARY
Chronic kidney disease has become a worldwide epidemic with approximately 26 million people being affected
in the United States alone. The primary cause of death in patients with chronic kidney disease (CKD)/ end
stage renal disease (ESRD) is from uremic cardiomyopathy and medial vascular calcification resulting in
cardiovascular death (CVD). The etiology of CVD in CKD/ESRD is multifactorial, and despite advances made
in treating the associated co-morbidities, the survival of patients with CKD/ESRD has not significantly
improved. Fibroblast growth factor 23 (FGF23), a phosphaturic hormone secreted by the bone, is elevated
early in CKD to maintain normophosphatemia, and, continues to increase with progression of CKD to ESRD to
supraphysiological levels. Epidemiological studies have associated FGF23 with increased cardiovascular
mortality/morbidity in CKD/ESRD. However, there is conflicting data regarding the direct effects of FGF23 on
the heart and the vasculature using animal models and human observational studies. Thus, the biology of
FGF23 is poorly understood and there is a need to determine the effects of FGF23 on the cardiovascular
system in kidney disease. The applicant's laboratory has developed an innovative mouse model with a
compound deletion of fibroblast growth factor receptors (Fgfrs) in the kidney: Kidney Conditional Fgfr1 and
Fgfr4 (KCFgfr1-/-/Fgfr4-/- mice) which results in chronic elevation of FGF23 levels without hypophosphatemia
due to renal resistance to the phosphaturic actions of FGF23. The applicant's long term goal is to identify the
role of FGF23 in health and kidney disease especially in regards to development/progression of CKD, renal
fibrosis, inflammation, bone mineralization, and neurocognitive functions. Using the above described mouse
model, the overall objective for this proposal is to identify the direct effects of FGF23 on the cardiovascular
system in kidney disease. Our preliminary data indicates that there is increased cardiac mass with chronic
exposure to FGF23 together with hyperphosphatemia at 6 months of age and there is increased aortic
calcification in 12-18 month old mice. We will determine the additional factors that FGF23 requires to cause
increased cardiac mass as KCFgfr1-/-/Fgfr4-/- mice have modest hyperphosphatemia, as seen in kidney
disease. We will use different dietary regimens to tease out which additional factors are required for FGF23 to
have the adverse effects on the heart: hyperphosphatemia, uremic toxins or a combination of both. With this
research proposal, we will also study the signaling pathways responsible for conversion of vascular smooth
muscle cells into a chondrocyte-like cells promoting vascular calcification. We aim to identify the Fgfrs
responsible for promoting vascular calcification in addition to the signaling pathways. The results from this
proposal will offer avenues for new therapeutic targets to mitigate the effects of FGF23 on the cardiovascular
system which will have a positive impact on the cardiovascular mortality/morbidity of patients with CKD/ESRD.

Public health relevance
PROJECT NARRATIVE This research proposal is highly relevant to public health due to its potential impact on affecting cardiovascular mortality/morbidity in patients with renal insufficiency and those who are on dialysis. Identifying the effects of fibroblast growth factor 23 on the cardiovascular system will have a tremendous impact on how the patients with renal disease will be treated. This project aligns with the NIH's mission to improve our knowledge and understanding of causes of cardiovascular disease in patients with kidney disease.